EARLY PHASE CLINICAL TRIAL TO EVALUATE ANTIVIRALS (APP)

To support a Phase I clinical trial to evaluate a promising new antiviral. The drug is intended to be used in an outpatient setting, a key objective of the Antiviral Program for Pandemics funded by the American Rescue Plan.